The RNA nanomachines of gene expression dissected at the single molecule level

ABSTRACT:
Since 2000, the PI has been awarded continuous NIH funding to contribute to the RNA field by building a broad
research portfolio focused on dissecting the mechanisms of the nanoscale RNA machines of gene expression –
ranging from small ribozymes and riboswitches to the RNA silencing machinery – by single molecule
fluorescence microscopy. Building on this expertise, the two long-term goals of the current MIRA renewal
proposal are to: 1.) Apply our established mechanistic enzymology approaches to an ever broader set of RNAs
involved in regulating mRNA transcription and translation, while seizing opportunities arising from the continuing
discoveries of new RNA functions. 2.) Push the technical limits of our approaches to be able to probe
increasingly complex biological machineries and mechanisms since unexpected discoveries – as we found –
often await where RNA nanomachines interact. In pursuit of these goals, we will address the overarching
hypothesis that both secondary and tertiary structures of RNA determine the outcomes of gene expression, in
often enigmatic and poorly understood ways that were traditionally overlooked by a field rooted in genetics,
where genes to this day often are drawn as sequence strings without structural features. Such thinking is
countered by, for example, the fact that nascent RNA structures have a significant impact on transcription in the
form of regulatory riboswitches embedded near the 5' ends of bacterial mRNAs that respond to specific ligands
by forming transcription terminator hairpins. In addition, the time-ordered, 5'-to-3' directional RNA synthesis
during transcription often yields kinetically trapped RNA folds distinct from the most thermodynamically stable
structure of a refolded full-length transcript. Encapsulating the power of our pursuit, we are combining our
signature single-molecule, biochemical and computational approaches to show that bacterial transcription
pausing frequently occurs at sites immediately downstream of both transcriptional and translational riboswitches,
which allows riboswitch ligands to affect transcription and transcription-translation coupling, respectively. In
addition, we are interrogating the mechanism of mammalian RNA silencing using single particle tracking both in
cultured human cells and reconstituted in human cell extracts. We posit that our work will continue to discover
more examples of intimate structural and kinetic coupling between RNA folding and gene expression, leading to
the exquisite gene regulation underlying all life processes. Ultimately, we anticipate that our studies have the
potential to transform our understanding of RNA structure-function relationships in general, and of how RNA
secondary and tertiary structure is governing the function of cellular gene expression machines in particular.

Public health relevance
PROJECT NARRATIVE: Building on a portfolio of long-standing expertise at the interface of RNA biology and single molecule biophysics, we will apply advanced mechanistic enzymology approaches to a broad set of RNAs involved in the regulation of transcription and translation, thus seizing the opportunities that continue to arise from discoveries of functional RNAs. In addition, we will push the limits of our single molecule approaches to be able to probe increasingly complex biological machineries and mechanisms in which RNA secondary and tertiary structures govern the function of the cellular gene expression machinery .